Assessing Effects of Microgravity on Cardiovascular Aging with AI and 3D Organoids

Project Summary
Astronauts often experience health challenges after spaceflight due to the body's adaptations to a
microgravity environment. This UG3/UH3 project aims to explore how spaceflight impacts heart health,
specifically focusing on the changes that occur in human heart under microgravity. Using stem cells,
we will create 3D heart-like tissues, known as vascularized cardiac organoids (vCOs), which contain
both heart cells and blood vessel cells. These organoids will be sent to the International Space Station
(ISS) to study the effects of spaceflight on their function over time, including changes in their ability to
beat, metabolize energy, and respond to inflammation. Our primary goals are to identify the biological
pathways disrupted by spaceflight and to evaluate potential drugs that could protect the heart from
these effects. We will use single-cell RNA sequencing, which allows us to observe how individual cells
respond to spaceflight, combined with computational drug screening to identify promising therapeutic
candidates. By comparing the responses of organoids in space with those grown on Earth, we aim to
gain insights into how microgravity and space radiation affect heart function and identify new strategies
for maintaining heart health during extended space missions. The findings from this study will improve
astronaut safety during long-duration missions, such as those to Mars, by identifying effective
countermeasures against space-induced cardiovascular changes. Additionally, the research could have
broader implications for understanding heart health on Earth, potentially benefiting individuals with
heart disease or inflammatory conditions. Our work seeks to bridge the gap between space-based and
Earth-based heart research, offering new perspectives that could lead to innovative therapies for
sustaining cardiovascular health in challenging environments.

Public health relevance
Project Narrative Physiological adaptations to microgravity and its detrimental effects on the cardiovascular system have been documented in astronauts during prolonged spaceflight missions. The current UG3/UH3 project aims to understand the effects of spaceflight on cardiovascular function by studying human iPSC- derived vascularized cardiac organoids (vCOs) under microgravity conditions. We will integrate advanced single-cell RNA sequencing, AI/ML, and multi-omics data with in silico drug screening to identify potential therapeutics that could mitigate spaceflight-induced cardiovascular changes.